Chronic stress-induced REDD1 expression in prefrontal cortex and cognitive inflexibility

PROJECT SUMMARY
Flexible behavior--
the ability to adapt behavior in response to changing environmental contingencies
--is a critical
component of everyday life.
Deficits in cognitive flexibility, a subconstruct in the cognitive systems domain of the
NIMH Research Domain Criteria (RDoC), are evident in many stress-associated neuropsychiatric conditions,
including major depressive disorder (MDD). Such deficits are debilitating, as they manifest as ineffective problem
solving and cognitive reappraisal as well as ruminating thought patterns that come at the expense of healthy
coping responses. Our preliminary data in mice demonstrate that a chronic unpredictable stress (CUS) regimen
produces deficits in strategy shifting (cognitive flexibility), akin to those observed in people with MDD, assessed
using an operant-based strategy set-shifting task.
These effects are sex-dependent, as they are more readily
observed in males relative to females. The human prefrontal cortex (PFC) has been implicated in flexible
cognitive control, and stress-related psychopathology is associated with functional and structural deficits in the
PFC. However, the cortical output pathways, affected pyramidal neuron subpopulations, and underlying cellular
mechanisms are not well-understood. In this proposal, we test the hypothesis that CUS produces sex-dependent
reductions in dendritic spine number and size in a subpopulation of pyramidal neurons in the prelimbic cortex
that express D2 dopamine receptors and project to the nucleus accumbens (NAc) core to produce deficits in
behavioral/cognitive flexibility. Based on observations that the protein REDD1 is increased in prelimbic cortex
following CUS and is elevated postmortem in the dorsolateral PFC of individuals diagnosed with MDD and that
overexpression of REDD1 in the prelimbic cortex produces deficits in set shifting, excitatory synaptic
transmission, and dendritic spine morphology, the proposal examines a mechanism wherein CUS increases
REDD1 expression in D2-expressing pyramidal neurons resulting in dysregulation of mTORC1 signaling and
disrupted actin cycling in dendritic spines. Aim 1 of the proposal will examine sex-dependent effects of CUS on
cognitive flexibility as assessed in our set shifting task and corresponding effects on synaptic regulation and
activity of NAc core-projecting D1 and D2 pyramidal neurons in the prelimbic PFC in mice. Aim 2 will examine
the contribution of increased REDD1 expression and disrupted TORC1 function in pyramidal neuron
subpopulations in the prelimbic PFC to CUS-induced deficits in cognitive flexibility. Aim 3 will examine the
contribution of disrupted actin cycling in prelimbic PFC neuronal subpopulations to CUS-induced deficits. To
pursue this project, we have brought together a team with complementary expertise in behavioral assessment,
stress neurobiology, systems neuroscience, in vivo and ex vivo physiological and morphometric measures to
assess alterations in neuronal activation, synaptic regulation, and dendritic spine structure. Understanding how
CUS dysregulates the prelimbic PFC to produce deficits in cognitive flexibility has implications for understanding
and treating a range of debilitating stress-related neuropsychiatric conditions.

Public health relevance
PROJECT NARRATIVE Many mental disorders involve deficits in cognitive flexibility which are worsened by the experience of chronic stress. This project will investigate stress-induced changes in neuronal subpopulations implicated in cognitive flexibility with the goal of developing better approaches for treating a range of debilitating stress-related neuropsychiatric conditions.